CATENIN AND CADHERIN SIGNALING IN DEVELOPMENT AND CANCER

Beta-catenin is a component of the cadherin adhesion protein complex and an intracellular signal transducing protein in the Wnt pathway. Beta-catenin is regulated by the APC tumor suppressor protein, and mutations in both beta-catenin and E- cadherin are implicated in many forms of cancer. The two overall objectives of the project are to determine the mechanism underlying the cytoplasmic regulation of beta-catenin signaling, and to determine how cadherins affect beta-catenin signaling, cell differentiation, and tumor cell growth. Nuclear import of beta-catenin is important for signaling and occurs by a novel mechanism involving its interaction with the nuclear pore. The mechanism of beta-catenin nuclear pore docking and its regulation by the Wnt signaling pathway will be studied. Beta-catenin signaling is regulated by a very large protein complex that includes APC, axin, and the kinase GSK3beta. The properties of the intact complex will be studied using an in vitro beta-catenin signaling assay, phosphorylation assays, and analyses of beta-catenin interactions. The complex will also be purified in order to identify key protein components. Furthermore, the role of a recently identified second APC protein, APC-2, in beta-catenin signaling in the early Xenopus embryo will be evaluated. Cadherin expression antagonizes beta-catenin signaling by binding it up at the plasma membrane, providing a potential mechanism to couple changes in cell adhesion to regulation of gene expression. The possibility that cadherin regulation of beta-catenin signaling plays an important role in development of the neural crest in the Xenopus embryo, an epithelial-mesenchymal transition, will be explored. Similarly, experiments will be done to determine the relative contributions of regulating beta- catenin signaling or enhancing cell adhesion to the tumor suppressor function of E-cadherin. Experiments will also be performed to determine whether E-cadherin can directly generate signals that mediate contact inhibition of cell growth. These experiments should help us understand the mechanisms of beta-catenin-mediated signaling and provide insights into the relationships between cell adhesion, tissue morphogenesis, and tumor growth.